Non-invasive Medical Device to Permeabilize the Blood-Brain Barrier Using Low Power Radio Frequency Evanescent Waves

The blood-brain barrier (BBB) is a highly selective semipermeable barrier that prevents bloodborne substances
from non-selectively crossing into the brain. However, the BBB also significantly impedes the delivery of
therapeutic agents into the brain. It has been reported that more than 95% of small molecule drugs and most
large molecule drugs fail to cross the BBB. This presents a major challenge to the delivery of pharmacological
agents for the treatment of various central nervous system (CNS) diseases, including Alzheimer’s and
Parkinson’s Disease, and brain cancers such as glioblastoma and brain metastases.
Several different approaches have been explored to make the BBB reversibly permeable, but to date, none have
received FDA approval. In addition, nearly all the medical devices currently under development are large,
expensive, and require surgery and/or treatment in a specialist clinic or hospital setting further adding to
treatment costs. Some examples include focused ultrasound guided by MRI to agitate injected microbubbles,
and pulsed ultrasound with a transducer array implanted in a skull window.
Evanesc Therapeutics has developed an innovative medical device designated EvaPermea to reversibly
permeabilize the BBB. Our non-invasive medical device uses low power radio frequency (RF) evanescent waves
that are delivered to the patient’s head via flexible antennas. The antennas are integrated into a cap that the
patient conveniently wears for only a few hours at home, with EvaPermea providing optimized RF dosage to
permeabilize the BBB prior to drug treatment. The device can be used in a non-clinical setting and allows the
patient to take the desired medications orally at home or via injectable routes. To the best of our knowledge, it is
the only medical device of this type that could be used at home and is low-cost and accessible to patients.
We hypothesize that the Evanesc’s device will provide a safe, effective, and convenient method for reversibly
permeabilizing the BBB. Our preliminary data support this hypothesis, demonstrating a substantial increase in
permeability of the BBB after treatment in vivo in a rat model. No adverse effects were observed. We will test
this hypothesis in three Specific Aims in this SBIR Phase I: Aim 1. Determine the optimal power, duration and
frequency of evanescent waves needed to effectively open the BBB. Aim 2. Determine kinetics of BBB closing
after optimal evanescent wave treatment. Aim 3. Assess the safety of evanescent wave treatment.
These studies will lead to the development of a low-cost, patient-friendly device for the safe and effective delivery
of pharmacological agents to the CNS, which would have a major impact on the treatment of many CNS
diseases. In our SBIR Phase II proposal, we aim to permeabilize the BBB and evaluate the efficacy of various
chemotherapy drugs, including Paclitaxel and Doxorubicin, in treating glioblastoma through in vivo studies. The
initial target market for EvaPermea is the treatment of glioblastoma and brain metastases, conditions that affect
200,000 people in the U.S. annually and have very low survival rates.

Public health relevance
The Blood Brain Barrier (BBB) is a semipermeable barrier that can prevent the effective targeting of pharmaceuticals into the brain, dramatically reducing therapeutic options for central nervous system (CNS) diseases. Currently, there are no FDA approved devices to facilitate the delivery of beneficial drugs into the CNS and approaches that are under development are expensive, may involve invasive procedures and can only be used in a specialized clinic or hospital setting. We believe Evanesc’s novel therapeutic device, EvaPermea, can fulfill this urgent, unmet need for a safe and effective method to reversibly open the BBB, which once optimized, can provide a low cost, patient-friendly, and non-invasive treatment to open the BBB and facilitate drug delivery with only a few hours of treatment in a home setting.